Oregon Alzheimer's Disease Research Center

Project Summary: Overall
The overarching goal of the Oregon Alzheimer’s Disease Research Center (OADRC) is twofold: 1) to focus on
early detection of change in order to define mechanisms supporting healthy brain aging and the transition to
MCI and early dementia, with an emphasis on multiple etiology dementias, including both AD and vascular
contributions to cognitive impairment and dementia (VCID), 2) to facilitate developing effective therapies to
prevent or limit these transitions and strategies to support patients and caregivers living with Alzheimer’s
disease and related dementias (ADRD), including in diverse and historically under-represented research
populations. To achieve these objectives, eight cores and a Research Education Component are organized to
catalyze and sustain innovative research and discovery in ADRD. The OADRC provides the necessary
materials to support research through well-characterized research participants, biological specimens, brain
tissue, data provision and analytics. The OADRC focuses on specific areas of emphasis: (a) Preclinical
dementia and disease progression emphasizing high risk populations of particular relevance to Oregon,
including the oldest old, Black/African American, and rural/isolated older adults, all of whom may experience
high barriers to healthcare access and thus are at elevated risk for ADRD, including VCID; (b) Markers of
meaningful change captured through studies of peripheral biomarkers, neuroimaging and continuous in-home
behavioral and activity monitoring, including known biological drivers of ADRD-pathology such as sleep; (c)
Neuropathology of brain aging and mixed etiology, including vascular dementia; (d) Novel testing of novel
treatments and caregiver support strategies, and (e) Provide venues and mechanisms for education and
training of new scientists, as well as bidirectional engagement with key stakeholders. To attain these goals
and objectives, the OADRC Specific Aims are to: 1. Catalyze and sustain innovative research and discovery in
ADRD through an organizational infrastructure supporting a rich collaborative environment composed of
leading edge technologies and methods, multi-disciplinary scientists, empowered research volunteers, and an
inspired community of lay and professional stakeholders with a commitment towards enhancing diversity
across our research, clinical, and educational pillars; 2. Focus the innovation and discovery infrastructure of
the center toward the five specific areas of emphasis mentioned above; 3. Share the necessary materials to
support the science through well-characterized research participants, biological specimens, brain tissue, data
provision and analytics, 4. Contribute to the national research commons relevant to Alzheimer’s disease and
related dementias, 5. Provide venues and mechanisms for education and training of new scientists, as well as
bidirectional engagement with key stakeholders such as members of the lay community, clinicians, patients
and family members to address the challenges of dementia, particularly among diverse and historically under-
represented populations.

Public health relevance
Project Narrative: Overall The Oregon Alzheimer’s Disease Research Center is uniquely positioned to discover new insights into healthy brain aging and the modifiable risk factors (vascular, sleep) that accelerate the pathogenesis of Alzheimer’s disease and related dementias, with a focus on under-represented groups in research including the oldest old, Black/African Americans, and isolated older adults (e.g., those living alone or in rural communities). This is facilitated by state-of-the-art approaches to clinical assessments (both in person and remote), standard longitudinal and novel neuroimaging markers of cerebrovascular disease and sleep-active glymphatic function, ultrahigh field 7T post-mortem imaging to enable radiological-pathological correlations, biomarker discovery, and innovative in-home digital technology allowing continuous objective monitoring of activity, sleep, and other important lifestyle metrics. We aim to widely share technological and statistical tools, participant and tissue resources, and data with not only the scientific community but also the public and other key stakeholders, with the ultimate goal of improving management and treatment for both patients and caregivers.